Electronic Health Record Phenotyping for Case Detection and Prediction of Emergency Department Visits for Child and Adolescent Suicide Attempts

PROJECT SUMMARY / ABSTRACT
The candidate requests support for a five-year program of training and research to better understand how
electronic health record phenotyping and other computational methods applied to existing medical record data
can bolster detection and prediction of suicide attempts by children ages 10 to 17. In the proposed training
plan, the candidate will build upon her previous experiences in social psychology, clinical informatics, and
clinical child and adolescent psychiatry to perform a multidisciplinary project at the University of California, Los
Angeles Health System. Her training plan includes developing skills and knowledge in 1) analysis of natural
language (text) data, 2) development of risk algorithms in healthcare settings to improve suicide prevention, 3)
basic qualitative research skills including modified Delphi Panel approach, and 4) the responsible conduct of
research. Suicide is the second leading cause of death of young people over 10 years old in the United States
and suicide attempts among children are common, costly and preventable. There is an urgent need to close
the gap between risk prediction algorithms and clinically-useable tools that can enhance medical decision-
making for providers and families. This study proposes that electronic health record phenotyping, a method of
standardizing case detection using clinical note text and structured medical record data, may offer improved
detection and personalized risk prediction for children, thus complementing existing suicide prevention efforts.
In the proposed research, using a cross-sectional design, Aim 1 will focus on adaptation of electronic health
record phenotyping to detect emergency department visits for suicide attempts by children using electronic
health records. Then, using a case-control design, Aim 2 will focus on development of risk prediction models of
emergency department visits for suicide attempts by children using longitudinal electronic health records over
two years. Aim 3 will focus on assessment of the validity, acceptability, usability, feasibility, and overall utility of
a personalized risk prediction prototype with case simulations using a modified Delphi panel approach. This
plan will parallel a training plan building skills and knowledge to bridge informatics, computational methods,
and clinical child psychiatry. In the long term, this research is an initial step to enhance signal detection and
support prediction of suicide attempts, in turn, setting the stage for deployment of personalized approaches to
prevention in clinical settings where providers, youth, and families may directly benefit.

Public health relevance
PROJECT NARRATIVE Suicide is the second leading cause of death among U.S. children: suicide attempts are common, costly, and preventable, and reduction in youth suicide is a national and international priority area. Computational approaches to predict risk of future suicide attempts using medical records have emerged as a promising means to address the crisis of youth suicide by identifying children who could benefit from early, evidence- based intervention before suicidal behavior occurs or escalates. This study seeks to improve detection and prediction of emergency department visits for suicide attempts among children aged 10 to 17 by newly adapting a computational method applied to existing medical records (electronic health record phenotyping), and then assessing the perceived added clinical benefit of an electronic health record-integrated personalized risk prediction software prototype among potential end users.